Circadian Mechanisms of Diabetes Prevention in Aged mice

Abstract
Caloric restriction (CR) extends life/healthspan in multiple species, although one drawback of CR is poor
compliance. This has led to alternative dietary approaches aimed at healthspan extension. We have established
an isocaloric twice-a-day (ITAD) feeding intervention wherein food is partitioned into two feeding intervals each
day, without CR. ITAD mice are fed at two 2-hour intervals each day such that total calories consumed are
similar to those eaten by ad-libitum (Ad-lib) controls in 24 hours. Despite absence of CR, ITAD-fed mice are
protected against diabetes and metabolic syndrome of aging. The mechanisms by which ITAD feeding mediates
these benefits remain unknown. Circadian-wide analyses revealed that ITAD feeding causes marked temporal
shifts in patterns of the quality control pathway autophagy. Surprisingly, ITAD mice show stimulation of
autophagy flux immediately after the 1st feeding window at 11am and marked suppression at 7pm. While
autophagy activation at 11am increases fat utilization, suppression of autophagy at 7pm associates with
inhibition of gluconeogenic gene expression and glucose production in aging mice. The mechanism by which
ITAD feeding suppresses glucose production is not known. Our recently published work has shown that core
clock proteins are targets for lysosomal degradation, and that autophagy specifically degrades CRY1. We have
found that autophagy is stimulated from 3pm to 7pm in livers from young Ad-lib-fed mice, leading to the timed-
degradation of CRY1¾a robust inhibitor of gluconeogenesis. CRY1 binds to the autophagosome marker LC3
through its LC3-Interacting Region (LIR) motifs. Acute autophagy blockage or inactivation of its LIR motifs
promotes CRY1 accumulation. Since CRY1 suppresses gluconeogenesis, its accumulation blocks
gluconeogenesis and lowers blood glucose. Interestingly, our preliminary data reveal that aged and obese mice
each display accelerated degradation of CRY1 by autophagy, leading to sustained gluconeogenesis and
hyperglycemia. Although autophagy flux typically decreases with age, we propose that age-related
hyperphosphorylation of CRY1, a modification shown to trigger its degradation, favors its sequestration and rapid
degradation by residual autophagy. From an interventional stand-point, our preliminary studies indicate that
ITAD feeding prevents the loss of CRY1 levels at 7pm by suppressing autophagy at this time-frame. We propose
that approaches preventing the age-related decline in CRY1 protein will normalize blood glucose levels and
prevent diabetes. On this premise, we hypothesize that age-related hyperphosphorylation of the core circadian
repressor CRY1 accelerates its autophagic degradation leading to hyperglycemia and type 2 diabetes. We
propose the use of two interventions to maintain CRY1 levels in aged mice, i.e., ITAD feeding, and small
molecules designed to mask LIR motifs of CRY1 and block its degradation that, in turn, will suppress
gluconeogenesis and prevent age-related diabetes. In this proposal, we will: (1) Determine the age and dietary-
stress-related changes in protein levels and lysosomal degradation rates of CRY1 and additional core circadian
proteins in liver; (2) Determine how age-related modifications to CRY1 accelerates its degradation and alters
gluconeogenesis; (3) Determine whether ITAD feeding reverses age-associated diabetes by increasing CRY1
levels, and (4) Identify small molecule inhibitors to block CRY1-LC3 interaction with potency, selectivity and
favorable drug-like properties and prevent hyperglycemia is aged mice.
Significance: Age-related metabolic syndrome/type 2 diabetes is a significant health problem in the United
States that increases sharply to ~44% in individuals older than 50 years. Type 2 diabetes impacts healthspan
through effects on cardiovascular and cerebrovascular systems, physical activity, vision, and cognition. Type 2
diabetes is thought to predispose to neurodegenerative disease, including Alzheimer’s dementia.
1

Public health relevance
Project Narrative Age-related diabetes/metabolic syndrome is a significant health problem in the United States that increases sharply to ~44% in individuals older than 50 years. Type 2 diabetes, a major predictor of reduced survival from cardiovascular events, is also thought to predispose to neurodegenerative diseases, including Alzheimer’s dementia. Studies in this application will dissect the interplay between autophagy and the core circadian protein cryptochrome-1 (CRY1) in prevention of age-related diabetes by isocaloric twice-a-day feeding. These studies aim to identify and develop novel small molecule compounds that will reverse diabetes by preventing the age-related decline in levels of CRY1 protein in liver.